Developmental Project Program

Project Summary
A major goal of the DF/HCC GI SPORE is to identify and support projects that test clinically meaningful
hypotheses and approaches aimed at reducing the incidence and mortality rates of GI cancers. To these
ends, a flourishing Developmental Research Program (DRP) supports short-range studies to establish the
results needed to facilitate well-validated, hypothesis-driven translational projects. The DRP's mission is to
foster new endeavors in GI cancer research, enable promising new individual and collaborative efforts,
promote novel technologies that enhance the community's research potential, and advance individual
projects from pilot to sustainable status. An important aspect of this mission is to identify and stimulate
interest in GI cancer research among established and junior investigators whose current focus may be
different, but whose ideas, expertise, and preliminary data have the potential for fresh and significant impact
on GI cancers. In addition to pilot funds and access to Core resources, projects and investigators
benefit greatly from integration and collaboration with a thriving community of GI SPORE investigators. The
DRP is led a highly qualified and invested committee that represents a full range of laboratory, clinical, and
population sciences across the DF/HCC member institutions. This committee actively identifies the best
talent, selects awardees through a fair and transparent process, and participates in ongoing review of pilot
projects and programmatic goals. In the prior funding cycle, DRP support for 19 innovative, diverse, and
specifically translational projects enabled novel discoveries, substantial contributions to the literature, and
more than 20 federal and foundation grants to sustain and advance GI cancer research. The DRP
incorporates the depth and flexibility necessary to maintain innovation in GI SPORE activities; notably, 3 of
the 4 main projects in this renewal application grew from original DRP support. The DRP will continue to
support novel research in GI cancer, with the following specific aims: 1) Solicit pilot projects in translational
GI cancer research that demonstrate significant potential for reducing the prevalence, suffering, and death
from the full spectrum of GI cancers; 2) Foster collaborative efforts among SPORE and other investigators to
enable the development of innovative ideas and laboratory and treatment approaches; 3) Monitor the
progress of developmental projects and provide investigators with critical, timely feedback; 4) Encourage
and assist investigators with promising preliminary data arising from DRP support to compete for peer-
reviewed extramural funding; and 5) When necessary and promising, promote the most meritorious DRP
projects to full SPORE research projects.

Public health relevance
Project Narrative The Developmental Research Program mission is to foster new endeavors in GI cancer research, enable promising new individual and collaborative efforts, promote novel technologies that enhance the community's research potential, and advance individual projects from pilot to sustainable status. This committee actively identifies the best talent, selects awardees through a fair and transparent process, and participates in ongoing review of pilot projects and programmatic goals.